Evaluating changes in parent infant interaction during early intervention: Diversity Supplement for 1R03HD113705-01Sharing Developmental, Meta, and Video Data from Preterm Infants Enrolled in the SPEE

Infants born very preterm (<32 weeks of gestation) are at risk of having developmental disabilities including
cerebral palsy, coordination impairments, attention deficit and learning disabilities. Impairments including
reduced postural control, movement variability, visual motor skills, and motor learning are common during the
first months of life and are associated with later developmental disabilities. However, infants born very preterm
rarely receive evidence-based therapeutic intervention in the first months of life when basic science and animal
intervention studies suggest the greatest efficacy. Barriers to enrollment in services delay the onset of services
and delivery models rarely support targeted preventative intervention or enhanced parent engagement during
the transition from the neonatal intensive care unit (NICU) to home.
Supporting Play Exploration and Development Intervention (SPEEDI) is an evidence-based intervention
that uses guided participation to empower parents in reading infant’s behavioral cues, identifying ideal times for
interaction, and enriching the environment and learning opportunities. Parents participate in 5 sessions in the 2-
3 weeks prior to NICU discharge while learning principles of engagement, readiness for interaction, and to
provide early motor and cognitive learning opportunities. Parents provide 20 minutes of motor and cognitive play
based enrichment daily for 12 weeks with bi-weekly physical therapist support (6 sessions). The parent is
empowered to determine the infant’s current abilities and advance the activities to the “Just Right Challenge”
throughout the 12 weeks, likely continuing after the intervention.
The proposed project with support the development of a shared dataset from this clinical trial including
developmental data from the infant, parent stress, dyadic interaction, and intervention fidelity data. The shared
data will allow other researchers to ask and answer questions ranging from development of preterm infants with
and without brain injury to efficacy of intervention.
Improved understanding of development and response to intervention will progress rapidly with share
data which can be harmonized with other datasets. This data is a crucial step toward meeting NIHs current
standards for share data that were not in place when this trial was funded.

Public health relevance
FROM PARENT AWARD The proposed research is designed to prepare developmental and clinical trials outcomes data from a cohort of 85 infants born very preterm for sharing in the Databrary and DASH repositories. The data includes infant and family level data plus videos of free play and parent child interactions that will allow a wide variety of researchers to use this data for secondary analysis. Improved understanding of development and response to a development intervention will help plan for future intervention research and implementation.